Examination of the dynamic relationships of sleep, physical activity, and circadian rhythmicity with neurobehavioral heterogeneity in ADHD

PROJECT SUMMARY
The goal of this study is to leverage wearable technology to investigate the dynamic relationships of objectively
assessed physical activity (PA; i.e., motor activity during wake time), sleep (SL), and 24-hour circadian
rest/activity rhythms (RARs) with heterogeneity in clinical symptoms and neurobehavioral phenotypes in
attention-deficit/hyperactivity disorder (ADHD). This project represents a new direction for PI Rosch, building
on her program of research on laboratory-based assessment of neurobehavioral functioning in youth with
ADHD, to incorporate objective tracking of daily activity/sleep patterns using wrist actigraphy. ADHD is a
heterogeneous condition both in terms of clinical presentation (e.g., inattention, hyperactivity, impulsivity,
cognitive disengagement syndrome [previously termed sluggish cognitive tempo], emotion dysregulation),
neurobehavioral functioning (e.g., cognitive control, delay discounting, and frustration tolerance), and
associated structure and function of cortico-subcortical brain circuitry. The factors contributing to this
heterogeneity remain unclear, but may be related to PA/SL/RARs which have been shown to separately relate
to these clinical symptoms and neurobehavioral functions. Hyperactivity, poor sleep (i.e., longer sleep onset
latency, shorter total sleep time, lower sleep efficiency, greater fragmentation and wake after sleep onset), and
altered RARs (i.e., weaker, more fragmented, less stable, and more delayed) are common in youth with ADHD.
However, there are critical gaps in our understanding of the dynamic (i.e., bidirectional, day-to-day)
associations among PA, SL, and RARs in the context of ADHD and associated heterogeneity in clinical
symptoms and neurobehavioral functioning, which is needed to better elucidate potential reciprocal
associations. Here we propose to address these gaps by examining the dynamic relationships of
PA/SL/RARs in children with ADHD by applying novel statistical modeling to objective wrist-actigraphy data
gathered in-lab and in natural “free-living” environments. We will do so among a well-characterized, deeply
phenotyped local sample of 200 children (8-12 years, 100 diagnosed with ADHD, 100 typically developing
controls) using a micro-longitudinal design (i.e., daily assessments of PA/SL/RARs and ratings of behavior and
emotion regulation over a 2-week period), and with lab-based assessments of delay discounting, cognitive
control, and frustration tolerance, and structural and functional magnetic resonance imaging (MRI). We will
also leverage the wrist actigraphy, neurocognitive, clinical, and neuroimaging data from the national
community-based Adolescent Brain Cognitive Development (ABCD) cohort of ~4,000 children with actigraphy
data collected while “free-living” for up to 3 weeks from children between the ages 9-13 years to conduct
complementary analyses. Findings from this project will inform our understanding of the factors contributing to
heterogeneity in neurobehavioral functioning and clinical presentation to guide the use of targeted and novel
interventions with wearable technology to improve outcomes.

Public health relevance
PROJECT NARRATIVE The goal of this project is to investigate the associations of sleep disturbances, altered circadian rest/activity rhythms (RARs), and physical activity with heterogeneity in clinical presentation and neurobehavioral phenotypes implicated in attention-deficit/hyperactivity disorder (ADHD). In addition to deeply phenotyping a local clinical sample of children with ADHD, the proposed study will also leverage ongoing and planned data collection in the Adolescent Brain Cognitive Development (ABCD) study, a population-based study of youth, for complementary analyses conducted in parallel. The knowledge gained has potential for transformative impact by elucidating the impact of modifiable factors on clinical and neurobehavioral heterogeneity in youth with ADHD, providing foundations for targeted intervention to improve long-term mental health and functional life outcomes.